BIOLOGICAL BASES OF ALCOHOLISM

Project Summary / Abstract
The overarching aim of this pre- and post-doctoral training program is to develop specialists who are able to
conduct basic research at levels ranging from the molecular to the cognitive/clinical, on the biological
mechanisms underlying the etiology, treatment and prevention of alcohol (ethanol) use disorders. Twenty
members of the graduate faculty of the Oregon Health & Science University (OHSU) serve as preceptors for
predoctoral students and postdoctoral research fellows in two graduate programs at OHSU—Behavioral
Neuroscience, and the Neuroscience Graduate Program. Major research interests represent areas of common
interest, such as genetic bases for ethanol responses and risk, learned and unlearned determinants of ethanol
reward, neurobiological bases for the rewarding, aversive and neuropathological effects of ethanol,
neuroadaptive mechanisms associated with repeated and/or developmental ethanol exposure, ethanol
dependence and sensitization, and effects of ethanol on memory, cognition and social behavior. In addition,
comparison to the effects of other drugs of abuse is of significant interest. Technical strategies reflect three
levels of analysis: I. Behavioral/cognitive/social, II. Neurophysiological/neuropharmacological/systems, III.
Cellular/molecular/genomic biological. Coordinated research efforts within the Portland Alcohol Research
Center (PARC), the Integrative Neuroscience Initiative on Alcoholism (INIA) and Oregon National Primate
Research Center (ONPRC) have strengthened training by unifying investigators and creating multidimensional
research projects. Training includes firm curricular grounding in the basic sciences, specific pharmacological
training in ethanol and drug addiction, and extensive and continuous participation in research. Four predoctoral
trainees per year will be supported by the training grant for 2-3 years, and then by individual National Research
Service Awards or their mentors' resources. Three postdoctoral trainees per year will be supported by the
training grant for 2 years. We have a well-developed plan for improving the diversity of our trainees and all
trainees are expected to complete an initial intensive course in the Responsible Conduct of Research, as well
as continuing education in this area. Ample opportunities exist for our trainees to be involved in public
education and outreach.

Public health relevance
Project Narrative Alcohol use disorder is a chronic, relapsing disease that directly affects approximately 15 million people just in the United States. The cost to society and individuals related to persons suffering from alcoholism is extreme. This training program will create experts capable of carrying on meaningful research on the biological mechanisms underlying the etiology, treatment and prevention of alcohol use disorder.